Administrative Core

ABSTRACT
Our proposed COBRE, Translational Approaches for Pathogens of Human Significance (“Pathogens”) addresses infectious diseases that are responsible for overwhelming morbidity and mortality. Tuberculosis, malaria, and schistosomiasis, the infections addressed by our first cohort of Research Project Leaders (RPLs) collectively cause 2 million deaths annually, about half of which are in children. Ebola virus disease, also addressed by our first cohort of RPLs, represents a major emerging and re-emerging threat with significant lacunae with respect to best approaches reduce mortality. The Pathogens COBRE’s Administrative Core will undergird all the activities of the program with the two primary goals of supporting four initial and subsequent RPLs in paths to research independence and creating a hub of scientific, mentoring, and administrative excellence to support the Pathogens COBRE. The Administrative Core will provide structure, evaluation, and benchmarking for the COBRE mentoring program, respond to all administrative and financial management needs for RPLs and Core Directors, and serve as a vehicle for programmatic innovation by implementing a disease-specific immersion program. The Administrative Core team will also coordinate our annual pilot research study program, organize an annual research symposium on Pathogens of Human Significance, and work closely with the Advisory Committee to evaluate all aspects of the COBRE.